Primary Mitochondrial Disease Expert Curation Panel

PROJECT SUMMARY. Primary mitochondrial disease is a highly phenotypically and genetically
heterogeneous group of progressive, multi-system disorders affecting 1 in 4,300 children and adults due to
impaired cellular energy metabolism. PMD patients on average experience 16 disabling symptoms, many
falling within high priority to NICHD, NINDS, and NEI, including intellectual or neurodevelopmental disabilities
with infection susceptibility that precipitates regression and/or metabolic strokes, vision loss, and increased
mortality. PMD are inherited disorders caused by pathogenic variants in any of hundreds of genes across both
nuclear and mitochondrial DNA (mtDNA) genomes. Accurate genetic diagnoses of PMD are essential to
harness increased actionability to initiate or avoid specific medications (e.g. anti-epileptics & anesthetics), co-
factors, modified diets, and cellular or gene therapies. Genetic diagnosis is also imperative for improved
recurrence counseling and prevention, medical complication screening, and FDA clinical trial inclusion. Yet,
establishing definitive PMD genetic etiologies remains challenging. Since 2012, the project Multi-PIs have led
the international Mitochondrial Disease Sequence Data Resource (MSeqDR) consortium to organize and
curate PMD genomic knowledge, informatics tools, and standardized ontology-defined phenotypes. Since
2017, the Multi-PIs have also gained approval as the ClinGen Mitochondrial Disease Expert Panel through the
NICHD-sponsored U24 program that engaged more than 30 international mitochondrial disease experts to: a)
curate Leigh syndrome spectrum (LSS) disorders for gene-disease association, b) establish variant curation
guidelines for actionable nuclear genes, and c) address the unique challenges of curating mtDNA variant
pathogenicity, including creation of consensus guideline revisions for mtDNA variant specification. In 2020, we
published a book, “Mitochondrial Disease Genes Compendium” that provides a readily accessible reference to
aide PMD understanding by clinicians and researchers from a gene-based perspective for 256 genes that had
variants associated with PMD in ClinVar as of Feb 2019. Harnessing these major advances, our ClinGen
Mitochondrial Disease Expert Panel now aims to expand from syndromic and organ-focused phenotype
curation efforts to take on the broader community need for expert panel curation of Gene-Disease associations
and mtDNA variant pathogenicity for all PMD in two Specific Aims. In Aim 1, we propose to complete Gene-
Disease association expert panel curation of 256 genes with ClinVar variants associated with PMD. In Aim 2,
we propose to perform mtDNA variant-disease expert panel curation of variants with reported pathogenic,
uncertain, or conflicting assertions in ClinVar for PMD, and work closely with ClinGen leadership to optimize
ClinGen infrastructure and informatics interfaces to support mtDNA variant curation using ClinGen-approved
mtDNA variant curation specifications. This effort will provide a definitive, expert-curated set of PMD genes,
and create lasting processes for expert curation of mtDNA genome variants within the ClinGen framework.

Public health relevance
PROJECT NARRATIVE Primary mitochondrial disease (PMD) is a phenotypically and genetically heterogeneous array of inherited cellular energy metabolism disorders that affect at least 1 in 4,300 children and adults with progressive multi- system problems, including neurodevelopmental disabilities, neurologic problems, muscle weakness, fatigue, exercise intolerance, heart disease, hearing loss, vision loss, hematologic and immune dysfunction. We will leverage our established expertise and experience in curating gene-disease and variant-disease relationships for pediatric Leigh syndrome spectrum disorders to now harness a highly collaborative international panel of mitochondrial disease experts to utilize the ClinGen framework and resources to perform expert panel curation of Gene-Disease associations and mtDNA variant pathogenicity assertions as well as clinical actionability for all PMD.